A novel remote blood separation device for at-home plasma collection for HIV-1 testing

PROJECT SUMMARY
There are 1.1 million persons living with HIV (PLWH) in the US with an estimated 13% who are unaware of their
infection. Antiretroviral therapy (ART) has been a successful approach to improving health outcomes for patients
and reducing transmission through maintenance of viral suppression. Current guidelines recommend PCR-
based viral load (VL) testing 2-8 weeks after initiation of ART and every 3-6 months thereafter to routinely confirm
medication adherence and maintenance of viral suppression. Without regular VL testing, it is not possible to
know a patient’s current state. However, there are currently no at-home based approaches for measuring VL,
which means that PLWH must regularly travel to clinical laboratory sites for a blood draw and testing. There is a
need for novel at-home collection and testing options for PLWH to 1) increase compliance with regular testing to
maintain viral suppression and 2) accommodate patients in low- to moderate-resource areas without easy access
to testing. Lo Biosciences seeks to transform remote specimen collection for PLWH by advancing development
of the P1 device, the first reliable collection approach for generating laboratory-grade plasma at home. This
approach is expected to enable patients to easily separate plasma at home and ship the specimen to reference
laboratories for analysis with gold standard PCR assays. The P1 uses magnetic bead-based separation, in which
functionalized beads capture red blood cells (RBCs) via antibody binding inside a custom tube. The tube is then
placed on top of a magnet, and the bound cells are pulled to the bottom in minutes. The supernatant plasma is
then squeezed into a standard blood collection tube for storage, shipping, and analysis. Prior to Phase I, LoBio
demonstrated effective removal of RBCs using the P1 device. However, for HIV VL testing, white blood cells
(WBCs) can introduce false positives due to proviral DNA/RNA. During Phase I, LoBio advanced the P1 device
to also significantly deplete WBCs and showed that the resulting plasma could accurately measure HIV VL after
1-2 days of simulated shipping conditions, demonstrating feasibility for at-home collection. The goal of this Phase
II project will be to complete development and manufacturing transfer, complete analytical validation of the P1
device for HIV VL testing, and complete method comparison and usability studies that are required for FDA
510(k) clearance of the device. At completion of this project, LoBio will seek FDA clearance. Commercialization
of the P1 device is expected to increase accessibility to laboratory testing toward increasing adherence to HIV
VL testing and enabling more patients to monitor their VL.

Public health relevance
NARRATIVE The use of antiretroviral therapies for HIV can significantly improve patient health and longevity outcomes, while effectively eliminating viral transmission, however, patients must regularly complete viral load testing to ensure they are in a state of viral suppression. Currently, there are no at-home methods for blood specimen collection or testing and patients must regularly visit clinics for testing, which is a barrier that can limit testing compliance and may not be accessible if patients do not have easy access to testing facilities. Lo Biosciences is advancing the first blood separation device that would allow patients to easily collect plasma at home and ship it to a laboratory for testing, which is expected to increase access and compliance with HIV testing.